BIOLOGICAL AGING AND COGNITIVE IMPAIRMENT IN PERSONS WITH HIV

PROJECT SUMMARY
This proposal will train the candidate to become a leading expert on the role of biological aging in cognitive
impairment that can affect persons with HIV (PWH). A detailed training plan has been developed, including
advanced coursework and instruction in the biology of aging and the epigenome, machine learning and
bioinformatics methods, and career-enhancing training through mentorship, leadership, and grant-writing
courses. This plan will both promote the success of the proposed Research Aims and set the candidate on a
trajectory toward an independent and productive career. Regular engagement with an experienced, multi-
disciplinary mentorship team will ensure the candidate’s success during the award period.
The proposed research study will investigate the relationship between HIV-related cognitive impairment and
biological aging, including aging of the central nervous system. While combination antiretroviral therapy has
improved life expectancy for PWH, cognitive symptoms persist in 20–50% of this population. Growing evidence
indicates that elevated biological aging is associated with adverse health outcomes for PWH. However, it
remains unclear whether accelerated aging still occurs in PWH with undetectable viral load, especially in diverse
populations at greater risk for comorbidities and adverse social determinants of health. It is also unclear how
biological aging relates to cognitive function in such populations. These questions are of crucial importance for
the health and quality of life of the aging population of PWH in the US.
The proposed study will address the central hypothesis that accelerated biological aging in PWH
contributes to cognitive impairment, in combination with comorbidities and social risk factors. The study will
represent a seminal effort to combine measures of biological aging from DNA methylation and brain
magnetic resonance imaging (MRI) with machine learning methods to build and test robust models of
cognitive impairment in PWH. This approach will be centered on two relatively novel but well-validated aging
biomarkers. Epigenetic age acceleration (EAA) will be measured using DNA methylation clocks, such as
GrimAge, which the candidate will derive from DNA methylation microarrays applied to blood samples from a
diverse group of PWH and control persons without HIV (PWoH). Analogously, deep neural network models will
be used to quantify brain-age acceleration (BAA) using volumetric brain MRI data from the same participants.
The ultimate goal is to leverage epigenomics and brain morphology data to produce a predictive
computational model of cognitive impairment. The role of non-AIDS HIV-associated comorbidities such as
cardiovascular disease and social determinants of health including neighborhood deprivation will be considered
in parallel with biological measures. This study will provide insights into the origins of HIV-associated cognitive
impairment, a major clinical problem that reduces quality of life for millions of PWH, and launch the applicant on
a unique research career in neuroimaging and aging biology.

Public health relevance
PROJECT NARRATIVE A substantial proportion of people with HIV experience cognitive impairment, despite effective multi-drug regimens targeting viral replication. This study will use DNA methylation profiling, magnetic resonance imaging, and machine learning methodology to investigate whether HIV infection and resulting cognitive impairment are associated with accelerated biological aging both in the epigenome and in the structure of the brain. This approach will help to clarify the mechanisms underlying cognitive impairment in people with HIV and may lead to better prognosis and clinical care for at-risk individuals.